The UCSD Microbiome and Metagenomics Center (Summit Supplement)

PROJECT SUMMARY
In the first gathering of quantitative researchers in the Nutrition and Precision Health Consortium, the primary
goal will be to provide a hands-on training experience working with NPH-like data and the All of Us Researcher
Workbench platform. A secondary and parallel goal is to continue to encourage and facilitate new, innovative
and collaborative research within and between NPH Centers. We will also demonstrate West Point AI, Data
Engineering, and Machine Learning NPH-like data repository and workshop participants will be able to conduct
search queries of the data repository, develop baseline scripts in Jupyter notebooks to interrogate the data and
set up novel research questions to eventually work with NPH data housed in the All of Us Researcher
Workbench. A major strength of the AI Summit is that they allow for data analysis based activities that facilitate
communication and exchanges of ideas between leading AI and machine learning data scientists in the field,
clinical center statisticians and early career faculty that want to develop Precision Nutrition Big Data analysis
skills. Such interactions and synergism are critical for initial analysis of the rich data sources arising from the
NPH and All of Us Research Hub. The AI Summit will provide a unique and exciting venue for NPH investigators
to cross pollinate between the 17 different geographically diverse institutions and lead to a future filled with new
and innovative collaborative projects in the Precision Nutrition.

Public health relevance
Project Narrative The proposed Artificial Intelligence Summit will be the first gathering of quantitative researchers in the Nutrition and Precision Health Consortium. The primary goal will be to provide a hands-on training experience working with NPH-like data and the All of Us Researcher Workbench platform. The summit is relevant to NIH and NIDDK’s mission because it seeks to train attendees in data analysis that will ultimately be used to help determine how nutrition and the microbiome can be used to improve people’s health and quality of life.